Cellular mechanisms of NLRP3 activation by ALCAT1 in diet-induced obesity

Obesity causes chronic “sterile” inflammation, which is implicated in insulin resistance and
other metabolic complications. NLRP3 (NLR family pyrin domain containing 3) is an intracellular
sensor for various “danger” signals from microbial infection and metabolic stress. Activation of
NLRP3 inflammasomes elicits host defense responses by promoting caspase 1-dependent
release of IL-1β and other pro-inflammatory cytokines. Intriguingly, activation of NLRP3
inflammasomes is also implicated in “sterile” inflammation and insulin resistance in diet-induced
obesity (DIO), yet the “danger” signals that lead to NLRP3 activation in obesity remains elusive.
Prions are misfolded proteins that are capable of self-transmitting their misfolded shape onto
normal variants of the same protein. Recent progress in the field has identified more than 240
non-infectious prion-like proteins in mammals. Although a few of these proteins are well implicated
in the pathogenesis of neurodegenerative diseases, surprisingly little information is known about
majority of the prion-like proteins’ potential involvement in human health and disease. Here, we
propose to investigate a novel pathway by which a putative prion-like protein regulates NLRP3
activation in DIO. This pathway is mediated by the ALCAT1 enzyme, the first acyl-CoA dependent
lysocardiolipin acyltransferase previously identified by us. Our groundbreaking work in the field
shows that ALCAT1 promotes the development of age-related metabolic diseases by catalyzing
pathological remodeling of cardiolipin (CL) with very long-chain polyunsaturated fatty acids, such
as docosahexaenoic acid (DHA). Enrichment of DHA renders CL highly sensitive to oxidative
damage (CL-Ox) by reactive oxygen species (ROS), leading to CL depletion and mitochondrial
dysfunction in metabolic diseases. Remarkably, our preliminary studies also identified a pivotal
role of ALCAT1 in linking DIO to NLRP3 activation as a putative prion-like protein, including 1)
ALCAT1 forms prion-like protein aggregates in response to oxidative stress, which is mediated
by a prion-like domain at the N-terminus; 2) ALCAT1 expression in adipose tissue is dramatically
upregulated by DIO; and 3)Targeted deletion of ALCAT1 in adipocytes significantly attenuates
NLRP3 activation by preventing macrophage infiltration in white adipose tissue. Together, these
exciting findings let us to hypothesize that ALCAT1 promotes NLRP3 activation in DIO as a
putative prion-like protein, which will be tested by three Specific Aims: AIM 1 will determine
whether ALCAT1 promotes NLRP3 activation through mitochondrial dysfunction; AIM 2 will
identify molecular mechanisms by which ALCAT1 promotes NLRP3 activation as a prion-like
protein; and AIM 3 will assess whether ALCAT1 links cellular senescence in adipose tissue to
chronic inflammation in DIO mice. Successful completion of the proposed studies will not only
validate ALCAT1 as a novel drug target of chronic inflammation, but also provide proof of concept
studies of targeting the enzyme for the treatment of obesity and its related complications.

Public health relevance
Obesity causes chronic inflammation without any obvious infection or autoimmune diseases. This chronic inflammation predisposes obese patients to various metabolic disorders, such as insulin resistance, type 2 diabetes, and diabetic complications. However, the underlying causes of the sterile inflammation remains poorly understood. The proposed studies will determine the role of the ALCAT1 enzyme as a key regulator of inflammation and insulin resistance, thereby a novel drug target for obesity and metabolic diseases.